Mechanisms of Immune Dysfunction after Trauma and Surgical Sepsis

Project Summary/Abstract
Trauma and Surgical Sepsis are among the leading causes of morbidity and death worldwide. Both of these acute
insults can lead to immune dysfunction that then contributes to a state of persistent critical illness. This immune
dysfunction is manifested by an excessive systemic inflammatory response that can lead to organ dysfunction;
and a simultaneous suppression of immune defenses that renders patients susceptible to secondary infections.
However, we lack a comprehensive and integrated view of how humans respond to severe injury, and more
importantly, how these responses differ between patients that recover quickly vs. those that die and/or
development persistent critical illness. Advances in single cell multiomics and blood analysis using multi-
platform, multiomics now makes it possible to characterize changes across a broad range of cell states and
patterns within the circulating biomolecule landscape to great depth. In the previous funding cycle, we were
the first to perform single cell genomics and large-scale multi-platform, multiomics on blood samples from
severely injured patients. This published work identified many novel findings, including the early massive
release of cellular constituents into the circulation of trauma patients that follow a complicated course or die.
In addition, open chromatin analysis of PBMC found that patients who remain critically ill also have global
epigenetic changes evident early across immune cell types, representing de-repression of polycomb targets. In
one line of research, we will reverse translate the these and other novel findings from our initial human
multiomic analyses into our mouse model of hemorrhagic shock and trauma to pursue potential therapeutic
targets. In another line of research, we will extend our analysis of multiomic data to create a Blood Atlas of the
human trauma response. This online resource will incorporate data on the range of circulating immune cell
states commonly seen after severe injury and integrate these with the longitudinal changes in high dimensional
datasets of circulating proteins, lipids and other metabolites. We will apply state-of-the-art computational
strategies to identify biomarkers and therapeutic targets with patients stratified by outcomes, treatments, age
and sex. We will compare our results with similar published studies in sepsis. In addition to the discoveries and
mechanistic insights our analysis will yield, we hope that the resources we provide will stimulate comparative
studies and further analyses of our datasets.

Public health relevance
Project Narrative Trauma and surgical sepsis frequently lead to death and/or persistent critical illness, however there are no targeted therapies to improve outcomes. With advances in technologies, we can now measure changes in gene and protein expression in thousands of cells at the single cell level and at the same time measure levels of thousands of biomolecules in the circulation. We will continue to apply these technologies to the study of trauma and sepsis to identify predictive biomarkers and identify novel therapeutic targets.